Texas A&M University Health Science Center Occupational Safety and Health Training Program

PROJECT SUMMARY
The Texas A&M University Health Science Center (TAMU HSC) Occupational Safety and Health (OSH)
Training Program delivers focused training in occupational safety and health, with available concentrations in
safety, health, and ergonomics for master’s level MPH students and environmental health for DrPH students.
Students completing the program possess knowledge and skills in the general concepts of developing
problems and solutions with cost/benefit analysis related to occupational safety and health/wellness,
ergonomics, human factors, industrial hygiene, occupational disease, human anatomy, user-computer
interaction, displays and controls, information processing, industrial process safety, epidemiology, vibration
control, and statistics. The TAMU HSC OSH Training Program has a long history of producing highly qualified
safety and health practitioners. The success of the program is demonstrated by the aggressive recruitment of
graduates by industry, healthcare, academia, and governmental agencies. Originally established in the TAMU
College of Engineering through the National Institute for Occupational Safety and Health (NIOSH)
―Ergonomics Training Grant from 1995-2003, the Training Program and course faculty transferred to Texas
A&M University School of Public Health (TAMU SPH) in 2002. The primary strengths of the TAMU HSC OSH
Training Program are the extensive faculty and staff expertise and experience in safety and health, medicine,
engineering, industrial hygiene, and ergonomics and the program’s critical ties to industry partners, enabling
capstone field training opportunities and internships for students and placement of graduates in professional
positions with industry leaders. Qualified students in the TAMU HSC OSH Training Program may pursue their
degree through a combination of on-campus, distance learning, or distributed learning methods. With NIOSH
TPG funding, this historically successful program will be able to continue to competitively recruit and retain the
best trainee candidates in the country. TAMU HSC OSH Training Program maintains a highly qualified and
successful faculty and professional staff, including professional engineers, medical doctors, certified
professional ergonomists, and certified industrial hygienists. For this renewal, the program is seeking to fund 5
master’s and/or doctoral level trainees each year for five years.

Public health relevance
PROJECT NARRATIVE Occupational safety and health specialists are critical to ensuring the safety and health of the nation’s worksites and workforce. This program addresses the shortage of qualified occupational safety and health professionals by delivering a high-quality program and successful graduates who meet the ever-growing industry demand. Program faculty integrate emerging issues related to workplace health and safety in the training of future OHS leaders.